Mechanisms of fungal involvement during intestinal disease

Abstract
The commensal microbiota has important impacts on host physiology and health that are only beginning to be
elucidated. Most current studies, however, have focused only on the bacterial microbiota despite the presence
of fungal, archaeal and viral members. The presence of anti-Saccharomyces cerevisiae (ASCA) antibodies
serves as a diagnostic tool for Crohn’s disease (CD) and suggests that fungal members of the microbiota
contribute to disease severity. Moreover, common genetic polymorphisms identified in individuals with IBD,
such as Nod2, Dectin-1, and Card9 are known to recognize fungal cell wall components. We have recently
demonstrated that one of the most prominent members of the mycobiota, S. cerevisiae, can exacerbate
intestinal colitis through upregulation of host purine metabolism in the gut. The end product of purine
metabolism in humans is uric acid. Recent studies have demonstrated that uric acid can have significant
impacts on autophagy. Coincidentally, many of the genes associated with IBD in humans, impact autophagic
processes. There is a significant body of clinical literature that links autophagy, yeast, and uric acid production,
yet these relationships have yet to be explored. Here we propose to identify how fungal members of the
microbiota induce purine metabolism from intestinal epithelia and determine how purine metabolism influences
intestinal immunity to worsen disease. We have brought together an inter-disciplinary team of investigators
with combined expertise in autophagy, fungal genetics and mucosal immunology to explore how yeast can
functionally influence intestinal disease.

Public health relevance
! Project Narrative The types of microbes that reside on the body are critical to the development of the immune system and maintenance of intestinal homeostasis. Most studies to date have focused on the bacterial members of this community despite the presence of fungi, archaea and viral species. This proposal will seek to understand how individual fungal species influence metabolism and immunity of the host and that dictate intestinal disease. These experiments have the potential to impact diagnostic and therapies to treat intestinal maladies.